The Role of Energy Balance in Gonadotrope and Reproductive Function

PROJECT SUMMARY
Polycystic Ovary Syndrome (PCOS) is the most common fertility disorder in reproductive-aged women. Women
with PCOS have elevated gonadotropin luteinizing hormone (LH), androgens, glucose, free fatty acids (FFAs),
and inflammatory cytokines. Concomitant increases in LH and testosterone in both women with PCOS and
mouse models of PCOS counter the well-established paradigm that testosterone suppresses the neuroendocrine
axis. Mechanisms behind this paradox are largely unexplored. LH translation and secretion are innately energy-
dependent processes. Therefore, gonadotrope cellular metabolism may explain the counterintuitive relationship
between androgens (anabolic steroids) and LH in PCOS. The overall goal of this proposal is to investigate the
impact of gonadotrope glucose metabolism on LH secretion and fertility in both normal and PCOS-like conditions.
The overarching hypothesis of this proposal is cellular metabolism in gonadotropes regulates LH synthesis; and
factors associated with PCOS, including glucose, androgens, and inflammatory cytokines, perturb gonadotrope
energy balance and therefore LH secretion. In Aim 1, we will define the metabolic program required for normal
gonadotrope function. We hypothesize that gonadotropes utilize glucose to support LH production and secretion.
We will test the impact of glucose deprivation on GnRH challenge in vitro and in vivo. In vitro, we will perform
comprehensive analysis of gonadotrope glycolysis and oxidative phosphorylation as they relate to nutrient
availability and LH secretion. In vivo, we will test the effects of gonadotrope specific glucose transporter 1
(GLUT1) knock out on female fertility. In Aim 2, we will decipher how androgens increase gonadotrope glucose
metabolism. We hypothesize that androgens increase gonadotrope utilization of glucose to drive LH secretion
by translational regulation of GLUT1. We will assess the impact of androgen on glucose uptake after silencing
GLUT1 in cell lines and use gonadotrope specific GLUT1 or androgen receptor KO mice to determine the role
of gonadotrope GLUT1 in PCOS. In Aim 3, we will elucidate the contribution of PCOS-induced inflammation to
gonadotrope metabolism and function. We hypothesize that chronic inflammation directly modulates
gonadotrope LH secretion and contributes to reproductive dysfunction in PCOS. Using complex bioinformatic
approaches, we will identify the immunophenotype specific to PCOS and assess the contribution of immune cells
to PCOS etiology using immune deficient transgenic mouse models. Together, these Aims will 1) outline a role
for gonadotrope energy balance in PCOS, 2) explain how androgens increase LH, and 3) identify specific
inflammatory pathways as potential therapeutic targets in PCOS. In the K99 mentored phase, Dr. Nicholas will
be trained in reproductive physiology and a PCOS mouse model that was established by her mentors. These
new skills will be combined with her previous expertise in immunology to launch a successful career dissecting
the role of inflammation in reproductive and metabolic disease.

Public health relevance
PROJECT NARRATIVE Women with polycystic ovary syndrome (PCOS) have pathologically elevated luteinizing hormone despite having high levels of testosterone, a known inhibitor of luteinizing hormone secretion. This proposal will address this incongruity by evaluating cellular metabolism and inflammation as potential mechanisms by which elevated androgens and luteinizing hormone coexist. By explaining this long-standing paradox, this work will identify alternative therapeutic targets, such as inflammation, for the improvement of fertility and metabolic comorbidities in PCOS.